Barcode screening of essential protein kinases in the life cycle progression of Trypanosoma cruzi

Summary:
Chagas disease, an infectious disease caused by the protozoan parasite Trypanosoma cruzi, affects 6 to 7
million people in the Americas, and its treatment has been limited to drugs with relatively high toxicity and low
efficacy in the chronic phase of the infection. New validated targets are urgently needed to combat this disease.
Phosphorylation-mediated signal transduction in eukaryotes plays key roles as regulator of protein function.
Considering the changes in phosphorylation patterns reported in T. cruzi developmental stages, it is likely that
protein kinases play a pivotal role in the regulation of cell cycle, metabolism, survival, and particularly in parasite
differentiation. Therefore, protein kinases, which represent near 2% of the T. cruzi genome, conform an attractive
group of molecular targets for antiparasitic interventions. In addition, the subcellular localization of protein
kinases is determinant for their activity and function. Therefore, elucidating their localization is crucial to predict
their participation in specific cellular processes. Programmable CRISPR/Cas9 systems have improved our ability
to produce precise genome manipulations in T. cruzi. However, current methodologies have limitations to further
perform the simultaneous analysis of multiple knockout mutants in T. cruzi, which also restricts the identification
of molecular targets for drug discovery. Here we will apply a protein kinase screening by gene knockout and
gene tagging in T. cruzi epimastigotes, to identify protein kinases involved in life cycle progression. We will
investigate 124 protein kinases of T. cruzi, most of them with no apparent orthologs in mammals. We will analyze
the phenotype of pooled knockout mutants harboring unique DNA barcodes that will be generated by
CRISPR/Cas9-based methodology. Furthermore, we will use next-generation sequencing to identify protein
kinases required for epimastigote survival, growth and differentiation into metacyclic trypomastigotes, and for T.
cruzi infection and proliferation in tissue-cultured host cells. Overall, we will perform a large-scale screening to
assess parasite fitness. We will also perform endogenous tagging of selected genes encoding protein kinases
to determine their subcellular localization. Elucidating the role of protein kinases in T. cruzi will allow to gain
insight organelle-associated signaling pathways required for parasite survival, proliferation and differentiation.

Public health relevance
Narrative: Trypanosoma cruzi is the etiological agent of Chagas disease, an illness affecting 6-7 million people worldwide, for which very few treatment options are available. Protein phosphorylation plays several key biological roles in the complex life cycle of the parasite, and protein kinases are known druggable targets in different eukaryotic pathogens. Here we propose to perform a barcode multigene-gene knockout screening in T. cruzi to identify essential protein kinases in the progression of the parasite’s life cycle.